Cause and therapeutic impact of DNA-protein crosslink repair defect in myeloid leukemias

ABSTRACT
Acute myeloid leukemias (AMLs) are a genetically heterogeneous group of clonal hematopoietic disorders
characterized by accumulation of immature non-lymphoid marrow progenitors. While there have been notable
therapeutic advances over the past 5 years, many AML subtypes continue to have case fatality rates of >50%.
Despite the introduction of a number of targeted therapies, conventional cytotoxic drugs – alone or in
combination with the targeted agents – remain the mainstay of AML therapy. Among the conventional cytotoxic
drugs used to treat AML, several act by increasing unique types of DNA lesions known as DNA-protein
crosslinks (DPCs). In particular, topoisomerase poisons increase the number of DPCs containing TOP2
(daunorubicin, mitoxantrone, etoposide) or TOP1 (topotecan) covalently bound to DNA. In addition, the
hypomethylating agents decitabine and azacitidine increase the number of DPCs containing DNA
methyltransferases covalently bound to DNA. The mechanisms involved in DPC repair are at present
incompletely understood. To facilitate the further development of topotecan and other TOP1 poisons, as well
contribute to the study of TOP1-containing DPCs, we have generated an antibody that specifically recognizes
TOP1-DNA covalent complexes (TOP1ccs). Using this antibody, we have shown that the nuclear
metalloproteinase SPARTAN and the serine protease FAM111A, acting upstream of the phosphodiesterase
TDP1, play important roles in the repair of TOP1ccs in some tissues. Importantly, loss of SPARTAN, FAM111A
or TDP1 leads to accumulation of TOP1ccs in the absence of drug treatment as well as enhanced sensitivity to
the prototypic TOP1 poison camptothecin. More recently, we have also observed that a variety of malignant
myeloid cells, including AML cell lines and primary AML specimens, contain readily detectable TOP1ccs in the
absence of drug treatment and are slow to repair TOP1ccs upon exposure to the TOP1 poison topotecan. In
contrast, the vast majority of tissues, including normal and malignant lymphoid cells as well as normal marrow,
contain very few TOP1ccs in the absence of drug treatment. These results lead to the hypothesis that many
myeloid neoplasms have previously unsuspected defects in TOP1cc repair that might affect their
therapeutic sensitivity. To test this hypothesis, we now propose to define the biochemical basis for the
constitutive increase in TOP1ccs in myeloid neoplasms (Aim 1), examine the impact of low TOP1cc repair on
leukemia cell sensitivity to agents that stabilize DPCs (Aim 2), and assess the relationship between TOP1cc
levels (constitutive and drug-induced) and clinical response of myeloid neoplasms to a topotecan-containing
regimen currently undergoing NCI-sponsored phase II clinical testing in high risk AML (Aim 3). Collectively,
these studies will provide important new insight into a previously unsuspected DPC repair defect in myeloid
malignancies and begin to determine whether this repair defect has therapeutic implications that can be used
to guide improvements in AML therapy.

Public health relevance
NARRATIVE Over 50% of patients who develop acute myeloid leukemia (AML) will die of this disease. While the development of targeted therapies has improved the outcome for some patients with this disease, these targeted therapies are usually administered in conjunction with conventional cytotoxic agents. Many of these conventional antileukemic drugs induce DNA-protein crosslinks, a type of DNA damage that has previously been difficult to measure. Here we use a recently derived immunological reagent to show that AML cell lines and clinical samples contain a previously unsuspected excess of these DNA-protein crosslinks. In particular, malignant myeloid cells exhibit elevated levels of crosslinks between the nuclear enzyme TOP1 and DNA even before being exposed to TOP1-directed drugs. We now propose to investigate the biochemical basis for the large numbers of pre-existing TOP1-DNA covalent complexes and assess whether the existence of these complexes predicts a favorable response to TOP1-directed anti-leukemic therapy.